Accelerated DNA Methylation Alterations in Hutchinson-Gilford Progeria Syndrome

PROJECT SUMMARY / ABSTRACT
Hutchinson-Gilford progeria syndrome (HGPS) is a rare genetic disorder characterized by the rapid onset
of premature aging beginning in childhood. The condition is caused by a mutation in the nuclear lamin LMNA
gene, which leads to the production of a dominant gain-of-function isoform of the protein, called progerin.
Progerin causes major disruptions to nuclear morphology and function, including nuclear protein export and
mitosis, replication stress, and contributes to increased DNA damage as well as the loss of heterochromatin
and dysregylation of other epigenetic marks, including cytosine-5 DNA methylation. We have recently provided
direct experimental evidence that aging-associated loss of DNA methylation at nuclear lamina-attached regions
of the genome is a direct consequence of cell division-associated DNA replication. We used this principle to
develop an epigenetic mitotic clock, called RepliTali, which provides a reliable estimate of cellular replicative
history. We hypothesize that altered DNA methylation patterns in patients with HGPS may contribute actively
to the severely accelerated aging observed in patients with HGPS. Here, we propose to conduct high-
resolution analyses of DNA methylation alterations in serially cultured HGPS cells and to investigate whether
we can extend the lifespan of HGPS model systems by manipulating DNA methylation patterns.
In Specific Aim 1 we will define DNA methylation dynamics in serially cultured HGPS fibroblasts from early
passage through replicative senescence using cost-effective Infinium DNA methylation arrays.
In Specific Aim 2 we will conduct high-resolution single-cell methylome analyses at key stages of HGPS
fibroblast culture to detect arising aberrations and delineate population transitions. We have developed a
single-cell whole-genome bisulfite sequencing (sc-WGBS) method that delivers genomic coverage far superior
to any other published sc-WGBS methods.
In Specific Aim 3 we will investigate whether DNA methylation manipulation can extend lifespan in HGPS
models. In Aim 3A we will test whether overexpression of DNA methylation writers and erasers increases the
replicative lifespan of HGPS fibroblasts. In Aim 3B, we will target DNA methyltransferase overexpression to
arterial smooth muscle cells in an HGPS mouse model to investigate whether this reduces arterial smooth
muscle loss and extends lifespan. We will monitor DNA methylation changes in this mouse model using a new
cost-effective DNA methylation array.
We present extensive and compelling preliminary data that demonstrates both the feasibility and relevance
of the proposed aims. The outcome of this proposed research could have important impacts on our
understanding of the contribution of DNA methylation alterations to HGPS phenotypes, potentially opening
avenues for new therapeutic approaches to treat progeria. In addition, this study could shed light on similar
mechanisms operating at a longer timescale in normal aging.

Public health relevance
PROJECT NARRATIVE Hutchinson-Gilford progeria syndrome (HGPS) is a rare genetic disorder characterized by the rapid onset of premature aging beginning in childhood. We propose to investigate whether disrupted epigenetic control contributes to some of the premature aging symptoms in HGPS. The outcome of this proposed research could potentially open avenues for new therapeutic approaches to treat progeria and shed light on the mechanisms in normal aging.